Cancer Biology

PROJECT SUMMARY/ABSTRACT–Cancer Biology Program
The overarching goal of the Cancer Biology Program (CBP) is to explore and understand the cell biology of
cancer. In working toward this goal, we lead integrated and transdisciplinary efforts to define pathways related
to cancer, identify driver mutations and genetic anomalies as new leads for therapeutic targeting, and explore
and exploit anti-cancer mechanisms as routes to translation into clinical trials. The Program is led by Martine F.
Roussel, PhD, an internationally recognized expert on the regulation of the G1 phase of the cell cycle and
proliferation as it relates to pediatric cancers, and Douglas R. Green, PhD, a world-renowned scientist studying
the mechanisms that dictate cell death and survival, including apoptosis, necroptosis, autophagy, and
metabolism in cancer and the immune system. They work together to translate discovery research to the clinic
by stimulating scientific exchanges, collaborations between our members and members of the other Cancer
Center Programs, and the active participation of our membership in meetings. CBP members are organized into
four programmatic working groups formulated to address unmet needs in the understanding of pediatric cancer
biology: Cancer Cell Signaling Networks and Therapeutics, Cell Death, Cell Stress Repair and
Metabolism, Tumor Microenvironment and Immunology, and Genome Structure and Function. CBP has
29 members, including 21 Full Members and 8 Associate Members (junior mentored) from 12 Departments.
During the current funding period, research in CBP has resulted in 570 primary research publications, of which
23.9% were inter-programmatic, demonstrating the key role of CBP members in supporting disease-focused
research through basic discovery, 12.8% were intra-programmatic, and 76.5% were inter-institutional (with other
NCI-designated Cancer Centers). 38% of our research publications were in journals with impact factor >10. This
work includes the genomic landscape of all pediatric cancers through the development of the Pediatric Cancer
Genome Project that unraveled the critical role of epigenetic regulators in cancer, fundamental insights into
mechanisms of cell death and cell survival, and elucidation of innate and adaptive immune functions impacting
our understanding of anti-cancer immunity. CBP members have a total of $6M in peer-reviewed funding. CBP
members have made a number of basic science discoveries have been translated into the clinic, greatly
facilitated by interactions with other SJCCC Programs. This includes FDA-approval of CDK4/6 inhibitors currently
in clinical trials for treatment of breast cancer and the repurposing of gemcitabine and pemetrexed for the
treatment of high risk medulloblastoma in collaboration with members of the NBTP. Because SJCCC is focused
solely on pediatric cancer, investigators study and develop trials for a diverse spectrum of pediatric cancers
utilizing a full array of therapeutic approaches. Consequently, our working groups are broad by design to
maximize opportunities for collaborative translation and to position the program well to address opportunities
and priorities as they emerge.